INSULIN INFUSION IN TYPE 1 DIABETES USING IMPLANTABLE PUMP

This clinical study is designed to demonstrate the reliability of the Infusaid Model 1000 Programmable Pump in delivering HOE 21 PH U100 insulin and to establish this treatment modality as a safe and effective means of managing Type I diabetic patients.